Exogenous fatty acid utilization by Staphylococcus aureus

PROJECT SUMMARY
Fatty acids are an indispensable part of life since they are an essential component of membranes. In addition,
they can serve a variety of other purposes, from an energy source to part of signaling molecules. Most bacteria
can generate their own fatty acids through a biosynthesis pathway. However, bacteria can also scavenge fatty
acids from the environment, including other bacteria and plant or mammal sources. This includes both free fatty
acids and as components of larger molecules. These external fatty acids can be used by bacteria to supplement
the fatty acid biosynthetic pathway or as an energy source. In Gram-positive bacteria, external fatty acids can
be incorporated directly to lipids through the FakAB system that was first discovered in Staphylococcus aureus.
In the case of pathogens like S. aureus, fatty acids are abundant in the host. However, the mechanism by which
the FakAB system functions is unclear due to limited biochemical and structural data. This will be the focus of
Aim 2. Many bacteria can also degrade external fatty acids using a fatty acid degradation pathway. However, S.
aureus has been thought to lack this pathway. Yet, a recent report and the preliminary data of this application
suggests otherwise. This system is the focus of Aim 1. In addition to these two pathways that would utilize fatty
acids, S. aureus transcriptionally responds to fatty acids. In the case of host fatty acids, this occurs at
concentrations that do not impact cellular growth and respiration, even though changes in these cellular
processes have long been proposed to be the reason why. Aim3 will build upon these studies to determine how
fatty acids impact S. aureus gene expression.
Specifically, Aim 1 uses newly constructed mutants combined with mass spectrometry to understand regulation
of the S. aureus fatty acid degradation pathway while also demonstrating its metabolic potential. Aim 2 uses
cell-based assays along with structural and biochemical assays, combined with key amino acid substitutions, to
interrogate the FakAB complex. Aim 3 builds upon prior research showing that S. aureus responds
transcriptionally to fatty acids. It utilizes RNAseq to dissect transcriptional responses to fatty acids as a signal
versus when their perturb metabolic function. It also uses protein topology studies to determine the mechanism
by which this occurs.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus is an extremely successful bacteria at causing human diseases. In this study, we will determine how key proteins in bacterial physiology impact the cell. These studies could lead to the development of new strategies for therapeutic tools to combat these infections.